Targeting exosomal PDL1 to improve immunotherapy

Project Summary - Project 1
Immune checkpoint inhibitors (ICI) such as anti-PD-1 antibodies have revolutionized anti-tumor therapy for many
types of cancers including metastatic melanoma. However, the patient response rates are low. Combined
therapies such as ipilimumab and nivolumab produce a higher response rate but are associated with significant
toxicities. A major unmet need is to develop quantitative assays that stratify patients who will respond to anti-
PD-1 therapy to avoid unnecessary toxicities, and direct non-responders to alternative treatments. Such a pre-
treatment or early on-treatment predictor would provide decision-enabling information to clinicians to optimize
the treatment of melanoma patients. While there is enormous interest and intensive efforts from both academia
and industry to identify predictors to response to ICI, the current biomarkers are suboptimal and early on-
treatment biomarkers are not available for any cancer types. Exosomes are nano-sized vesicles secreted by
cells to the extracellular milieu. We found that metastatic melanoma cells secrete exosomes enriched with PD-
L1, which suppress the function of CD8+ T cells in circulation and facilitate tumor growth. In patients’ plasma, the
level of circulating exosomal PD-L1 (“exPD-L1”) and its change during the course of anti-PD-1 treatment are
associated with the patient response to anti-PD-1 therapy (Chen et al., Nature 2018). Most recently, we found
that tumor associated macrophages (TAM) also secrete exosomes that carry PD-L1 (“TAM-exPD-L1”), which
can be selectively and quantitatively measured in patient blood. TAM exosomes effectively suppress the
proliferation and function of CD8 T cells. The overarching goals of Project 1 are to develop a quantitative liquid
biopsy-based tool that enables clinicians to predict the patient response to ICI-based therapies, and to
understand the role of TAM-derived exosomes in immune suppression. In Aim 1, we will test the hypothesis that
exPD-L1, and especially TAM-exPD-L1, individually or in combination, are effective predictors of patient
response to ICI. We perform the assays using a large multi-institutional validation set of patient samples across
different major therapeutic contexts, taking advantage of the unique infrastructure SPORE offers. In Aim 2, we
will systematically investigate the pivotal roles of TAM-derived exosomes in immune suppression using
melanoma-macrophage co-culture system, humanized mouse system, and exosomes purified directly from
patient tumor tissues. Together, our work will establish exosomal PD-L1 as a rationale-based clinically relevant
stratifier that warrants future development for clinical diagnostics. The proposed study will also unveil a role of
TAM exosomes in immune suppression, which will not only advance our understanding of immune suppression
at new dimensions, but also helps develop novel therapeutic approaches to improve the treatment of patients
with melanoma.

Public health relevance
Project Narrative - Project 1 Despite the recent progress in immune checkpoint inhibition (ICI)-based therapies, the patient response rate is low. Rationale-based biomarker development is urgently needed to stratify responders and non-responders, thereby providing decision-enabling information to clinicians and patients. The study of tumor- and macrophage- derived exosomes proposed in this application will unveil novel mechanisms of immune suppression, and help develop a quantitative liquid biopsy-based tool that enables clinicians to predict patient response to ICI-based therapies.